Neurosurgery research training in interdisciplinary neuroscience

The University of Washington has a long and strong tradition of training residents in neurological surgery for careers in academic medicine. This proposal will support the research component of this training by placing the resident in an interdisciplinary research environment, preparing the candidate for neurosurgically-inspired science projects and a future career as an interdisciplinary investigator in funded projects. Future candidates will pursue topics in one of three core strengths of ongoing department work ? Neural Engineering, Neuro Oncology, and Restorative Medicine. The 12-month experience (extendable to 18 months) will include independent investigation in the context of a mature project to ensure success. Combined with a didactic program that is supported by the department and superior clinical experience, the resident will be prepared to begin a career as a physician-scientist in a collaborative neural engineering project at the conclusion of the support period.

Public health relevance
This research program is a critical part of the residency training in Neurological Surgery at the University of Washington School of Medicine whose goal is to train outstanding academic physician-scientists. It has a spiraling design that will introduce residents to skills and principles of research program design, critical evaluation, and data presentation and interpretation. These will be developed through four steps leading to well-developed skills including grant- proposal writing.